Neurochemical mechanisms governing footshock-induced suppression of methamphetamine intake

PROJECT SUMMARY
One feature of methamphetamine use disorders (METH-UD) is that some people will continue taking METH
despite negative psychosocial consequences while others will stop under the same conditions. Understanding
the mechanism governing the differences between these groups will enable the development of new
pharmacotherapies for METH-UD and will be important in addressing the ongoing health crisis. To model this
phenomenon, scientists developed a preclinical punishment model which uses punishment conditions (e.g.,
increasing footshock intensity, FSI) paired with METH self-administration to differentiate shock-sensitive (SS)
and shock-resistant (SR) rats. However, though widely accepted in the field, the current version of the
punishment model is limited by its reliance on subjective and arbitrary endpoints to distinguish SS from SR
groups and thus is limited in its robustness, reproducibility, and reliability. To address the weaknesses inherent
in the current punishment protocol, we developed a novel quantitative and objective approach which we named
the Quantitative Punishment Model with Clustering (QPMC). The QPMC obtains several variables from the
METH taking behavior before and after the punishment regimen, followed by clustering to objectively
determine distinct groups. We present preliminary data that suggests that QPMC is superior to the current
punishment model with regards to identifying populations that are truly biochemically distinct. Wider adoption of
QPMC will require more extensive comparisons between the two models. The objective of this proposal is to
evaluate our new QPMC in comparison to the current punishment model. We propose to do this through two
specific aims. In Aim 1, we will compare QPMC and the current punishment model in their ability to identify two
biochemically distinct groups of rats self-administering sucrose pellets and METH (0.1 mg/kg/infusion). Given
that the METH dose may alter the punishment sensitivity, Aim 2 will examine the effect of a changing METH
dose on the reliability of the QPMC relative to the current punishment model. Animals from both aims will be
evaluated for expression of corticotrophin releasing hormone stress systems, opioid peptide systems, and
CART peptide systems in the nucleus accumbens. These molecular pathways will serve as molecular
endpoints to establish biochemical distinctions between the identified groups per QPMC and the current model.
Our general hypothesis is that, compared to the current punishment model, QPMC will objectively reveal
distinct populations of rats self-administering METH under the punishment paradigm and will identify different
endophenotypes for METH intake, leading to clearer understanding of the mechanisms that govern METH-UD.

Public health relevance
PROJECT NARRATIVE A widely accepted preclinical punishment model allows researchers to separate laboratory animals that develop METH Use Disorder (METH-UD) from those who do not. However, several critical limitations compromise the robustness and reproducibility of the data generated through this model, mainly the subjective cut-off criteria that could vary between laboratories. To address these problems, we propose to develop and validate a new quantitative method that can objectively distinguishing different populations of subjects taking METH under punishment conditions.